Augmenting cognitive-behavioral therapy with rTMS of the medial prefrontal and anterior cingulate cortices for the treatment of cocaine use disorder

Project Summary/Abstract
Cocaine use disorder (CUD) continues to be a significant public health problem in the U.S. and more
effective treatment strategies are needed. Repetitive transcranial magnetic stimulation (rTMS) is a non-
invasive method of modulating specific brain regions that has shown preliminary efficacy in the treatment of
CUD. However, sham-controlled clinical trials assessing cocaine consumption in CUD are lacking.
Previous imaging studies in CUD have implicated broad regions of the prefrontal cortex, including the
medial prefrontal cortex (mPFC), anterior cingulate cortex (ACC), and dorsolateral prefrontal cortex (dlPFC).
Alterations in connectivity and cortical thickness have been shown to correlate with treatment response in CUD
across different imaging modalities in each of these brain regions. Thus, our goal is to employ rTMS, using the
H7-coil, since this coil can simultaneously and bilaterally stimulate the mPFC and dorsal ACC. Additionally, the
H7-coil has been FDA-cleared for obsessive-compulsive disorder (OCD), based on its ability to reach these
broad, deeper regions within the prefrontal cortex. As a result, treatment centers using the H7-coil are found
across the United States (in 42 of 50 states), meaning that the use of this coil could move from the laboratory
to the clinic relatively quickly.
In this application, we first propose an outpatient double-blind sham-controlled trial (UG3 Phase) to
investigate H7-coil feasibility, brain-behavior mechanism(s) using fMRI, and effect on initiation of abstinence
from cocaine when administered prior to cognitive behavioral therapy (CBT). If the proposed go/no-go criteria
are met, we will recruit a larger sample to evaluate the efficacy of combined rTMS/CBT for abstinence initiation
in adults with CUD (UH3 Phase). If the UH3 data support therapeutic efficacy, this treatment could rapidly
translate to the clinic given existing FDA-clearance for the H7-coil in psychiatric populations (i.e., OCD), and
could become the first FDA-approved therapy for CUD.

Public health relevance
Project Narrative Cocaine use disorder is prevalent in the U.S. and recent increases in the rate of cocaine-related deaths are concerning. Medications for cocaine use disorder have not shown consistent results and none have received FDA approval. Repetitive transcranial magnetic stimulation (rTMS) is an effective, FDA-cleared treatment option for patients with mental health disorders that have not responded to other treatments, including obsessive-compulsive disorder, and rTMS may be an effective strategy for cocaine use disorder.